The Role of Pacs1-Wdr37 inLymphocyte Quiescence and Survival

PROJECT SUMMARY
Naïve lymphocytes exist in a quiescent state until becoming activated by antigen. Their continued
survival depends on signals they receive through their antigen receptors and from homeostatic cytokines.
How naïve lymphocytes respond to pro-survival signals while continually maintaining quiescence is unclear.
This is an important issue: enhanced responses to survival signals can fuel malignant transformation while
impaired quiescence can trigger spontaneous immune activation and immune failure. We have recently
discovered a new protein complex containing phosphofurin acidic cluster sorting protein-1 (Pacs1) and WD
repeat protein 37 (Wdr37) that is required for normal lymphocyte survival and quiescence. Mice lacking
Pacs1 or Wdr37 were deficient in circulating B and T cells. Pacs1-Wdr37-deficient B cells exhibited
spontaneous proliferation in vivo coupled with increased apoptosis which indicated loss of cellular
quiescence. These cells demonstrated increased levels of endoplasmic reticulum stress in vitro and were
hypersensitive to oxidative stress. Importantly, Pacs1-Wdr37 deficiency did not impair humoral immune
responses. However, it potently suppressed lymphoproliferative diseases resulting from blocked apoptotic
pathways. Mechanistically, deletion of Pacs1 or Wdr37 impaired antigen receptor-dependent calcium (Ca2+)
release from the endoplasmic reticulum (ER) due to transcriptional downregulation of ER Ca2+ release
channels (inositol triphosphate receptors, IP3R). These results lead us to hypothesize that Pacs1-Wdr37
integrates antigen receptor-dependent Ca2+ signaling and cellular stress responses to promote lymphocyte
survival and quiescence. We will test this hypothesis by (i) elucidating how disruption of Pacs1-Wdr37
diminishes B cell survival and quiescence; (ii) defining how Pacs1-Wdr37 prevents ER stress and promotes
IP3R expression; and (iii) validating Pacs1-Wdr37 disruption as a therapeutic approach to B cell
malignancies.
Relevance to public health:
Signaling networks that permit lymphocyte survival are often co-opted during malignant transformation.
There is a need for therapies that subvert pro-survival signaling in diseased lymphocytes while preserving
most beneficial immune functions. This proposal will investigate a novel protein complex involved in
promoting lymphocyte survival and quiescence while preventing cell stress that is a promising therapeutic
target for lymphoid malignancies.

Public health relevance
PROJECT NARRATIVE Malignantly transformed lymphocytes co-opt growth and survival signaling networks used by healthy lymphocytes. We have identified a new protein complex containing Pacs1 and Wdr37 that promotes lymphocyte survival through its effects on endoplasmic reticulum stress response pathways and calcium signaling. This proposal investigates how Pacs1-Wdr37 controls the survival of healthy and transformed lymphocytes with the intention of validating a new therapeutic target for lymphoid malignancies.